HYPERPOLARIZED 13C MRSI FOR THERAPEUTIC RESPONSE MONITORING OF PROSTATE CANCER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Early detection of prostate cancer therapeutic response is necessary to choose the most appropriate treatment plan. Taking the advantage of cancer specific aerobic glycolysis, known as the 'Warberg effect', metabolic imaging with hyperpolarized 13C-labeled pyruvate (pyr) has demonstrated potential of early detecting prostate cancer;a potentially better alternative to conventional therapeutic response monitoring taking months to become apparent. In this technique, the transient fate of pyr and its downstream metabolites lactate (lac), alanine, and bicarbonate is measured with 13C Magnetic Resonance Spectroscopy Imaging (MRSI) following an injection of hyperpolarized pyr. Our aim is to investigate the efficacy of this technique in order to monitor the therapeutic response of prostate cancer to radiotherapy. To read about other projects ongoing at the Lucas Center, please visit http://rsl.stanford.edu/ (Lucas Annual Report and ISMRM 2011 Abstracts)